Innovative Pneumothorax Decompression Device

Project Summary/Abstract
The proposed project relates to the development of an innovative, single-operator pneumothorax
decompression device that aims to improve the safety and time efficiency of therapeutic decompression. The
aim of neonatal pneumothorax decompression is to alleviate built-up air pockets inside the chest wall that
threaten the functionality of vital organs. Current procedures require a medical provider to assemble a
functional decompression “device” using multiple off-the-shelf modular components, which can be inefficient
and time consuming in emergency situations. Two medical providers are generally required to achieve the
therapy, which involves insertion of a needle into the chest wall with no feedback of needle depth. In addition,
the needle is subject to movement, potentially harming surrounding lung tissue, as stability of the needle
within the chest cavity is based solely on provider skill and steadiness. An innovative prototype device will be
designed, manufactured and evaluated.

Public health relevance
Project Narrative This project involves creating a new device to assist providers in treatment of pneumothorax, which is a life- threatening condition in which air escapes the lungs causing the chest wall to expand and compress the lungs. Pneumothorax can occur in adults or children, but it is generally more severe in newborns as the lungs are not fully developed. The project will build and evaluate a new tool for the treatment of pneumothorax.